Teamwork, Targets, Technology, and Tight Control in Newly Diagnosed Pediatric T1D: 4T Study

Project Summary:
The goal of the 4T study is to implement proven methods and emerging diabetes technology into our clinical
practice to sustain tight glucose control from the onset of type 1 diabetes (T1D) and optimize patient reported
and psychosocial outcomes. We will define a program (4T---Teamwork, Targets, Technology and Tight
Control) translatable to Pediatric Diabetes clinics in the United States that reduces HbA1c and T1D burden and
improves patient well-being.
In response to the R18 mechanism, we have designed a pragmatic approach to study a re-designed diabetes
education and care delivery program in newly diagnosed Pediatric T1D patients. The primary outcome will be
to implement 4T education and care in newly diagnosed T1D patients to reduce the rise in HbA1c observed 6
months post-diagnosis. We will compare results to historic data from our clinic and to contemporaneous new
onset HbA1c data in the USA and internationally. Our secondary aims are to refine a systematic, pragmatic
approach to monitoring longitudinal Patient Reported Outcomes and Psychosocial Outcomes and to develop
and test in a randomized trial an automated system to detect the need for insulin dose adjustment in between
quarterly visits. We will do so by using glucose data to generate personalized management recommendations
based on each patient’s physiological and psychosocial data.
The research outlined in this proposal aims to lower HbA1c, develop glucose data management and
communication systems and support the psychosocial challenges of T1D in a program that is practical,
sustainable, and translatable to other Pediatric Diabetes clinics in the US. Specific innovations will be to
develop: 1) best practices for providers & T1D patients for glucose and psychosocial outcomes; 2) systems to
identify patients with changing insulin needs based on glucose data obtained in between visits; 3) integration of
these glucose data into EMR to incorporate into routine clinical practice.
In sum, we propose leveraging existing staff and resources to test an innovative approach to improve T1D
treatment in our clinic with the goal of obtaining results that will improve healthcare practice and inform
healthcare policy for T1D management. We will assess factors that inform sustainability, acceptability, and
feasibility. By design, the approach being tested is practical and sustainable with the potential to be broadly
disseminated across the US and to improve processes of care and health outcomes for the Pediatric T1D
population.

Public health relevance
Project Narrative: To improve care in newly diagnosed Pediatric type 1 diabetes patients we propose using a combination of (4T) Teamwork, Targets, and Technology to maintain Tight glucose control to optimize patient glucose and psychosocial outcomes. We will use an integrated approach to care and develop automated glucose data management and psychosocial monitoring systems that can be translated to other US clinics to optimize glucose control and reduce burden on patients, families, and health care teams. The research outlined in this proposal aims to lower HbA1c, develop glucose data management and communication systems and support the psychosocial challenges of T1D in a program that is practical, sustainable, and translatable to other Pediatric Diabetes clinics in the US.